Sequencing Technologies & Analysis Shared Resource

SEQUENCING TECHNOLOGIES & ANALYSIS SHARED RESOURCE – ABSTRACT
The Sequencing Technologies & Analysis Shared Resource (STA-SR) provides cost effective, rapid DNA
sequencing and genomics analysis to members of the Cold Spring Harbor Laboratory (CSHL) Cancer Center.
The Shared Resource is led by Faculty Co-Heads W.Richard McCombie, Ph.D,. and Molly Gale Hammell, Ph.D,.
along with co-managers Sara Goodwin, Ph.D., and Ying Jin, PhD. Over the last five years, 33 Cancer Center
members (87% of members) used squencing and/or bioinformatics services Overall, 80% of total sequencing
use and 93% of bioinformatics use was by Cancer Center members over the last five years, resulting in 95
publications/preprints. The STA-SR has allowed Cancer Center members to access state-of-the-art sequencing
instrumentation and bioinformatic resources to support an array of endeavors, including: cancer genome and
exome re-sequencing, de novo cancer genome sequencing, RNA-Seq, Chip-Seq, RIP-Seq, sequencing of
custom gene panels and re-sequencing of single-cell genomes and transcriptomes. The large volumes of data
created from these methods have necessitated both basic and advanced bioinformatics support. The STA-SR
has taken a proactive role in building the computational infrastructure required to support these varied genomics
projects. During the past five years, the STA-SR worked to develop robust long read sequencing protocols to
support cancer research while also remaining abreast of the most current short-reads sequencing methods.
Complementary to the technological advances, the STA-SR has developed novel computational tools for
sequencing data analysis, established standard pipelines for sequencing data analysis, built powerful
computational servers to support data analysis for the CSHL cancer community, and trained the students and
postdoctoral scholars at CSHL to use both the technologies and computational tools. One major goal is to
continually upgrade and improve technological and computational support structures to ensure the long-term
sustainability of sequencing and data analysis at the CSHL Cancer Center. The second major goal is to
contribute scientific, resource-based, infrastructure that remains at the forefront of cancer research. Specifically,
during the next five-year period, the STA-SR intends to continue developing long-read technologies and related
computational tools to address the newest questions at the forefront of cancer research. Additionally, the STA-
SR will work closely with other Shared Resources and individual labs on project specific technologies and tools
such as single-cell sequencing studies and studies involving design of CRISPR RNAs.

Public health relevance
SEQUENCING TECHNOLOGIES & ANALYSIS SHARED RESOURCE – PROJECT NARRATIVE Not required per PAR-20-043